Remotely-Delivered Programs Targeting COVID-19 Stress-Related Depression and Substance Use

Project Summary/Abstract: Remotely Delivered Programs Targeting COVID-19 Stress-Related Depression and Substance Use The COVID-19 pandemic presents an unparalleled level of everyday stress and is likely to increase rates of depression and substance use, potentially overwhelming behavioral health treatment capacity. We have developed a new program (CHA MindWell; CHA-MW) to address the anticipated surge in demand for behavioral health services for our safety-net health system’s health system’s diverse and socioeconomically disadvantaged population. It has both a screening/monitoring/referral and an early intervention component: First, we implemented remote computerized adaptive testing (CAT-MH®) to stratify patients at risk of stress- related mental illness into 3 tiers: Minimal symptoms or low-risk (Tier 1), mild-to-moderate symptoms or at-risk but not meeting criteria for in-person treatment (Tier 2), and moderate-to-severe symptoms requiring treatment (Tier 3). In standard CHA-MW, CAT-MH is delivered online by email to participants monthly to determine if they are Tier 3 and referral to mental health treatment is needed. Second, Tier 2 patients are referred to a live, online psychoeducational program - Mindfulness-Based Cognitive Therapy for Resilience (MBCT-R), which is an 8-week group adapted from MBCT, which is effective for treatment of stress, anxiety, and depression (known risk factors for substance use), and preventing relapse among patients with recurrent depression. MBCT-R will therefore have impact both during and after COVID-19. When participants enroll in MBCT-R they receive enhanced CHA-MW (i.e., weekly in addition to monthly CAT-MH monitoring), allowing us to closely determine if a higher level of care becomes necessary. We will randomize Tier 2 patients who have mild-to- moderate symptoms of depression (CAT-Depression Inventory 50-75, PHQ-9 equivalency 10-20) in a 3-arm comparative effectiveness RCT to compare MBCT-R + enhanced CHA-MW weekly monitoring to either: a) enhanced CHA-MW weekly monitoring alone (with rapid referral to mental health treatment if needed), or b) an asynchronous internet CBT (iCBT) application + CHA-MW weekly monitoring. We expect MBCT-R to reduce depression symptoms (primary outcome), stress, and indirectly prevent substance use (secondary outcome). For a sub-study within the RCT, we will collect preliminary data using daily diaries to measure stress-related affective reactivity data (upticks in negative affect and/or reductions in positive affect during stress days) and adaptively sample salivary inflammatory cytokines (IL-6, TNF-a, IL-1b) remotely on 2 high and 2 low stress days before and after the interventions. Because this pragmatic effectiveness trial of a live, online mindfulness- based intervention with naturalistic remote monitoring is already embedded in our safety-net health system, it can be implemented immediately and disseminated rapidly if effective at reducing depression symptoms, and could impact behavioral health systems nationally during and after COVID-19 and future public health crises.

Public health relevance
PUBLIC HEALTH RELEVANCE: As the COVID-19 pandemic presents unprecedented challenges for increased symptoms of stress, anxiety and depression in the general population, Cambridge Health Alliance (CHA) seeks to study the impact of an innovative approach (CHA MindWell) to this unique public health crisis in a vulnerable and diverse underserved population. Patients in the CHA primary care network will be monitored regularly via remote computerized adaptive testing of mental health symptoms and substance use (CAT-MH ®) and then provided options for mental wellness interventions or rapid access mental health treatment if needed. This Randomized Controlled Trial seeks to randomize patients in the CHA primary care network with mild to moderate depression (N=200) to compare the effectiveness of a remotely-delivered live, online Mindfulness-Based Cognitive Therapy for Resilience intervention (MBCT-R) + enhanced CHA Mindwell (i.e., with weekly CAT-MH monitoring and referral to treatment if needed) (Arm 1; n=80) with self-guided internet Cognitive Behavior Therapy (iCBT) + enhanced CHA Mindwell (Arm 2; n=80), and enhanced CHA Mindwell alone (Control Arm 3; n=40) on depression and substance use symptoms over a 24-week period.